Mechanisms and SMN-Independent Therapies for Spinal Muscular Atrophy

Project Summary
Mutations in the Survival of Motor Neuron 1 (SMN1) gene and low levels of its translated product, the SMN
protein, provoke the frequently fatal, infantile-onset neuromuscular disorder, spinal muscular atrophy (SMA).
Afflicted individuals invariably carry a copy gene, SMN2. However, SMN2 produces only residual protein
owing to a splicing defect. Still, given the cause of SMA and the invariable presence of SMN2 in patients, it is
not surprising that the copy gene has served as the most common target for the treatment of the disease. The
strategy of targeting SMN2 is embodied in one FDA-approved agent, Spinraza®, which restores the SMN
protein by correcting the splicing defect in the gene. Small molecule modulators of SMN2 and therapies that
exploit viral vectors to directly restore SMN add to the choice of therapeutic agents that replenish the protein to
treat patients. While these developments and SMN repletion in general, raise considerable optimism for the
treatment of SMA, they have done little to shed light on precisely how SMN paucity preferentially disables the
neuromuscular system. Besides, it is still quite uncertain if restoring SMN as currently practiced will be
curative or merely delay the onset of disease. Already it is clear that the most effective outcomes require early
treatment; symptomatic patients derive considerably less benefit, and it would not be surprising if even pre-
symptomatic treatment merely converts a fatal disease into a chronic one. Here we propose experiments that
address gaps in our understanding of the basic biology of SMA as a means to better and more assured clinical
outcomes. Accordingly, in Aim 1, we wish to identify a novel determinant of the SMA phenotype by exploiting
strain-specific differences in model mice that turn a severe form of the disease into a remarkably mild one. We
hypothesize that the gene/factor in question is related to a chaperone modifier we have identified and thus
likely shares functions with the chaperone in what could imply a novel pathway, synaptic proteostasis, in SMA.
In Aim 2, we will focus on the original chaperone modifier with experiments designed to explore its potential as
a novel therapeutic target for the treatment of motor neuron disease. We propose that the chaperone, via its
effects on proteostasis, potentiates neurotransmission at the neuromuscular synapses of individuals afflicted
with SMA. Finally, in Aim 3, we will investigate how reduced SMN in skeletal muscle contributes to the
neuromuscular SMA phenotype. We posit that low SMN affects muscle, at least in part, through its effects on
resident progenitor cells, disrupting the ability of these cells to self-renew and thus impairing muscle repair and
regeneration. If successful, the project will a) identify a novel suppressor of the SMA phenotype, b) reveal a
distinct neuromuscular disease-relevant pathway that impacts disorders like SMA and, c) explain how SMN
maintains skeletal muscle – the underlying rationale for targeting this tissue to optimally treat the human
disease.

Public health relevance
Project Narrative Spinal muscular atrophy (SMA) is an oft-fatal motor neuron disease caused by low SMN protein. SMN repletion appears to benefit some patients, but very little is known about how the protein protects the motor neurons and muscle, or if the currently available SMA treatments will be entirely curative. Here we wish to investigate these vitally important questions. Our research will result in a fuller understanding of the biology of SMA and is thus expected to inform improved treatments for this and similar neurodegenerative disorders.